A Mouse Model to Test the Effects of Gender-affirming Hormone Therapy on HIV Vaccine-induced Immune Responses

Project Summary
Biological sex impacts the immune system, as evidenced by differences between men and women in vaccine-
induced humoral responses. There is a considerable gap in knowledge, however, surrounding the
immunological responsiveness of transgender people, a population at considerably higher risk for HIV and
other STIs. To address this gap, we propose to develop an animal model of feminizing hormone therapy to
study the effects of estrogen/anti-testosterone therapy on HIV vaccine-induced immune responses.
Cross-sex hormone therapy (XHT) is the most common approach for transition-related care, but immunological
studies of transgender individuals are generally limited to case studies. Animal models of gonadectomy and/or
supranormal hormone treatment have implicated sex hormones as potent modulators of the immune system,
with estrogens generally appearing to enhance immune responses and testosterone inhibiting them. However,
ambiguous (and sometimes paradoxical) observations have obscured an overarching consensus for sex
hormone effects on immunity. In recent years, mouse models of XHT have provided important insights into
effects of prolonged hormone therapy on bone physiology, reproductive function etc., but information on the
effects of sex hormone therapy on immune responsiveness is scarce.
For this project, we will develop a mouse model of XHT that recapitulates clinical hormone therapy for
male-to-female transition in humans. We hypothesize that mice and humans share sets of immune-related
genes that are impacted by a feminizing hormone regimen, and that mice undergoing XHT will exhibit altered
immune responses to a HIV vaccine compared to control male mice. To test these hypotheses, we will define
the relevance of this mouse model to human transition-related care through a single-cell transcriptomics
approach to define differentially expressed genes in control and XHT mice, and then compare these cell-type
specific sets of differentially expressed genes to those obtained from the same analyses of people undergoing
feminizing hormone therapy (pre and two years post-initiation of hormone therapy) (Specific Aim 1). To test the
effects of hormone therapy on in vivo vaccine responses, we will immunize control male mice and XHT mice
with a HIV vaccine regimen that is highly sensitive to sex-dependent factors (Specific Aim 2).
Should this study reveal an immunoregulatory effect of feminizing hormone therapy on HIV vaccine
responsiveness in mice, it will provide a new platform for assessing the effects of sex hormones on vaccine
responses. Moreover, this animal model could then be used to test various vaccination parameters (adjuvant,
dose, interval, etc.) for sex hormone-dependent effects, with the ultimate goal of designing an HIV vaccine that
maximizes efficacy but minimizes adverse outcomes.

Public health relevance
Project Narrative Men and women differ in their immune responses to vaccination, with women mounting stronger reactions but suffering from higher incidences of adverse effects. In transgender individuals undergoing gender-affirming hormone therapy, it is unclear to what extent hormone treatment impacts immune responsiveness to vaccination. To understand the effects of feminizing sex hormone therapy on vaccination, we propose to develop a mouse model of gender-affirming hormone therapy, assess its relevance to human medicine through singe-cell transcriptome studies, and test the immune responses of “cis” vs. “trans” mice to a HIV vaccine.